Patient-Specific Coronary Hemodynamics by 3D Printing

ABSTRACT. Despite improvements in therapies targeted at reducing disease burden, CAD continues to afflict
>16 million US adults, accounting for more than 1/3 of all deaths and responsible for ~1.2 million
hospitalizations annually. Coronary revascularization remains a mainstay of treatment for CAD, with >1.2
million percutaneous interventions performed annually in the US. Prior multicenter trials have demonstrated
propitious outcomes for individuals with who undergo ischemia-guided revascularization by fractional flow
reserve (FFR)—an invasive “gold” standard that determines the physiologic significance of coronary stenoses.
More recently we have studied the accuracy of a non-invasive CT-based alternative to FFR, termed FFRCT.
While this new method is moderately accurate, it possesses several limitations such as assuming the walls of
the coronaries are rigid and flow is non-pulsatile. Therefore, we have determined an alternative approach to
assessing coronary hemodynamics via 3D printing, which allows physical measurements of coronary flow
using realistic tissue mechanics and pulsatile flow. In this application, we will optimize the hardware, software,
workflows, and analysis to build and evaluate coronary hemodynamics based on patient CT images.
Extensive clinical imaging data, including 15O-H2O labeled PET imaging will be used to validate the accuracy of
these models for predicting coronary hemodynamics. Finally, these 3D printed models will be used to develop
clinically useful reports that can provide diagnostic determination of a patient's level of ischemia using only
non-invasive CT imaging.

Public health relevance
PROJECT NARRATIVE. The goal of this proposal is to build and optimize the equipment, software, workflows and analysis to create anatomically accurate 3D print coronary flow models with realistic tissue mechanics. Extensive clinical data will be leveraged to validate these 3D printed coronary models against patient measurement and images, such that the anatomic and hemodynamic factors are all properly recapitulated. Finally, results from these 3D printed models will be used to develop clinically useful reports that can provide diagnostic determination of a patient's level of ischemia using only non-invasive CT imaging.